Assessing correlation between antimicrobial resistance genes and susceptibility phenotypes for Enterobacter cloacae complex isolates from the Vet-LIRN AMR monitoring program and clinical samples

Project Summary
Enterobacter cloacae complex (ECC) are a natural component of mammalian gastrointestinal
microbiota (Davin-Regli and Pagès, 2015; Ramirez and Giron, 2020), but also found in a wide range of foods
and can potentially serve as foodborne pathogens (Healy et al., 2010; Shaker et al., 2007;Capita et al., 2020;
Gwida et al., 2014; Kilonzo-Nthenge et al., 2013). A recent study has identified multi-drug resistant ECC in raw
tomatoes, lettuce, carrots and other fresh vegetables that were intended for direct human consumption in
Spain (Pintor-Cora et al., 2023).
ECC and E. aerogenes are recognized as the most predominant nosocomial clinical pathogens within
the Enterobacter genus, often linked to infection outbreaks (Davin-Regli and Pagès, 2015; Mezzatesta et al.,
2012). Over the past three decades, they emerged as highly significant opportunistic, and multi-drug resistant
pathogens in hospital settings (Gaston, 1988). These infections, ranging from urinary tract infections,
pneumonia, bacteremia, and sepsis, pose significant risks particularly for immunocompromised individuals
(Annavajhala et al., 2019; Girlich et al., 2021; Intra et al., 2023). Antimicrobial resistance (AMR) in
Enterobacteriaceae represents a global public health concern (John Jr et al., 1982; Ramirez and Giron, 2020).
Klebsiella species and Enterobacter species, including ECC isolates, are recognized as the most prevalent
carbapenem-resistant Enterobacteriaceae (CRE) in the United States (Annavajhala et al., 2019; Lutgring,
2019; Mezzatesta et al., 2012).
In recent years, many antibiotics commonly used to treat Enterobacter infections, including ECC-
associated diseases, have been alarmingly less effective(Sanders Jr and Sanders, 1997). This trend is
attributed to the intrinsic β-lactam resistance observed in ECC species, primarily due to expression of low
levels of ampC genes encoding for an inducible AmpC-type cephalosporinase (Annavajhala et al., 2019;
Seeberg et al., 1983). This unique chromosomal β-lactam mechanism enables ECC species to resist the
bactericidal effect of Penicillins and first- and second-generation Cephalosporins. In cases of prolonged
exposure to β-lactam drugs, ECC species may even exhibit resistance to third generation Cephalosporins
(Seeberg et al., 1983).
The Vet-LIRN AMR monitoring program has collected and sequenced approximately 200 ECC strains,
and determined their corresponding AMR phenotypes. KSVDL routinely receives ECC-positive diagnostic
samples. The objectives of this project are to isolate ~20 ECC isolates from KSVDL submitted specimens,
obtain genome sequences and determine AMR phenotypes, then perform a comparative analysis of AMR
phenotypes of these ECC genome sequences alongside the 200 ECC strains from the Vet-LIRN AMR
monitoring program.

Public health relevance
Project Narrative Correlation between antimicrobial susceptibility phenotypes and presence of major groups of antimicrobial resistance genes will be studied. Different mutation types, including point mutations, insertion and deletions, as well as potential segment rearrangement, and mutation rate of each type will be analyzed. Additionally, genetic diversity and phylogenetic relationships of the major AMR genes as well as potential correlation of AMR susceptibility levels to AMR gene diversity will also be studied.